Predoctoral Training in Biomedical Sciences

Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text.
The UCSF Biomedical Sciences (BMS) PhD program provides interdisciplinary training to equip students with the scientific and intellectual skills needed to rigorously address important problems in the biomedical sciences with increasing self-direction, and with the adaptability and professional skills that will foster their success once they enter the biomedical research workforce. With its goals closely aligned with those of the NIGMS Molecular Medicine program area, the BMS program is unique among UCSF training programs and addresses a national need for rigorous training of scientists who wish to apply basic and translational research approaches to dissect the mechanistic underpinnings of human disease. Students emerge from the training program with a record of scientific achievement and opportunities to contribute to the biomedical scientific enterprise in accord with their own interests. We pursue these goals through a combination of coursework, mentored research, and other structured training activities. The BMS curriculum provides a foundation in cellular and molecular biology, genetics, tissue and organ biology, and biostatistics and computational biology, integrating the analysis of human disease states throughout. It provides opportunities for deep exposure through small group discussion-style minicourses and includes courses on human biology and disease that incorporate discussion with clinicians and patients. Training in the methods to enhance research reproducibility and scientific rigor is threaded through the first-year curriculum and is reinforced by laboratory training and mentorship, as is the development of skills in evaluating, proposing and communicating research. Career exploration and professional development is emphasized from the beginning of the student experience and supported by robust program and institutional resources, optional internships, and professional mentorship from program faculty, all of whom participate in the UCSF-wide Graduate Faculty Development Program that provides mentorship training. Selection for appointment to the training program is conducted through an application process at the beginning of students’ first year of study. Support continues in the second year of study but students maintain deep engagement with the T32 program throughout their time at UCSF through their involvement in our unique Translational Mentor Program for T32 appointees. The grant currently supports 12 trainees annually (i.e., 6 per cohort), drawn from a large pool of eligible students enrolled every year (typically 21) who demonstrate a strong motivation to participate in T32 training activities. Intended program outcomes include degree completion in 5-6 years, generation and communication of a body of rigorous and impactful biomedical research, and successful transition to research-related careers in the biomedical workforce.

Public health relevance
The mission of the UCSF Biomedical Sciences PhD training program is to train the next generation of leaders in the biomedical sciences, equipping them with the knowledge and skills to perform rigorous and reproducible research that will uncover the biological mechanisms that underlie human health and disease. We prepare trainees for success in a variety of careers in which they will contribute to the biomedical research enterprise. Society will benefit from the discoveries and treatments that will result from the training of scientists who are motivated and able to apply fundamental and patient-based research approaches to advance human health.